RECEPTOR AGGREGATION ON THE CELL SURFACE

The binding of a ligand to a cell surface receptor is the first step in a cascade of events that leads to the generation of a transmembrane signal. In many cell systems, simple ligand binding is insufficient to initiate signal transduction, rather, receptor aggregation is required. On the surface of mast cells, basophils and rat basophilic leukemia (RBL) cells are Fc receptors (Fc-epsilon-RI) which bind IgE with high affinity. The formation of aggregates of IgE or equivalently of the Fc-epsilon-RI receptors triggers various cellular responses. However, it is not clear what physical and steric conditions must be met by the IgE-receptor aggregates in order to initiate signal transduction. The goal of this project is to understand receptor aggregation in general and in particular to determine the properties of an IgE-receptor aggregate that are required to initiate particular cellular responses. To do this we will use multiparameter flow cytometry to simultaneously measure the kinetics of ligand binding and crosslinking of cell surface IgE with changes in intracellular Ca2+ levels. We will develop and test mathematical models that predict the time course of the IgE aggregate distribution that is formed when surface IgE is crosslinked by these ligands and relate this aggregation to cellular responses. We expect that the results of these studies can be generalized to other receptor systems in which receptor aggregation is involved in signal transduction. The studies in this project are health related bearing on allergic reactions as well as ligand receptor reactions in general.